Mayo Alzheimer's Disease Research Center

PROJECT SUMMARY - OVERALL
The Mayo Clinic Alzheimer’s Disease Research Center (ADRC) has been operating at the Mayo Clinic Rochester
(MCR) and Mayo Clinic Florida (MCF) since 1990. The theme of the current cycle of the ADRC is Multiple
Etiology Dementias. We recruit and follow participants on the Alzheimer’s disease (AD), frontotemporal lobar
degeneration (FTLD), Lewy body disorders (LBD) and vascular cognitive impairment dementia (VCID) spectra
to study the roles of multiple pathologic processes functioning to impact cognition in aging. We will be evaluating
the social and structural determinants of health in African American/Black and Hispanic/Latino communities at
MCF and rural residents at MCR to determine the manner in which the multiple pathologic processes evolve in
these communities. Our team has secured several grants in AD, FTLD, LBD and VCID to allow us to leverage
the resources of the ADRC against these projects to advance our knowledge. New cores in this ADRC
application include the Genomics Core that will study the role of multi-omic aspects of various
neurodegenerative and cerebrovascular disease (CVD) disorders, and a Digital Innovation Core that will
combine aspects of artificial intelligence neuroimaging, gait, speech/language and remote cognitive
assessments to help diagnose and evaluate the longitudinal outcome of neurodegenerative and CVD disorders.
The Biomarker Core will evaluate several plasma assays and platforms to determine the utility of these plasma
markers in predicting the underlying pathologies, assisting in the biological aspects of the diagnosis and following
treatments of these disorders. The Neuroimaging Core will continue to unify imaging protocols across
modalities between MCR and MCF as well as move the field forward with defacing MRI and PET images to
maximize research participant privacy. Our Neuropathology Core has been at the forefront of developing
neuropathology criteria and serves the vital function of confirming the multiple etiological nature of most
degenerative/CVD conditions. The Data Management and Statistical Core will continue to lead the field in
electronic data capture for our Center enabling the robust sharing of data. The Research Education
Component has been successful at training the next generation of investigators from underserved populations
and will expand these efforts. The Mayo Clinic ADRC will continue to be a leader in sharing images, data and
biospecimens with the other ADRC’s and the broader research community. The unique focus of the Mayo Clinic
ADRC involving the combinations of most of the major neurodegenerative and CVD disorders will advance the
field for refining diagnoses leading to the development of therapies.

Public health relevance
NARRATIVE – OVERALL The Mayo Clinic Alzheimer's Disease Research Center (ADRC) will pursue the theme of Multiple Etiology Dementias. The ADRC will intensely focus its efforts on the recruitment on African American/Black, Hispanic/Latino, and rural dwelling communities, and will assess for all ADRC participants' structural and social determinants of health to evaluate the impact of multiple pathologies. Mayo ADRC will share its data, images, and biological specimens widely with the ADRC community and other investigators.